Elucidating the roles of alveolar macrophage inflammation and self renewal during influenza infection

Summary
Respiratory viral infections, such as influenza and SARS-CoV-2, pose significant public health challenges,
particularly affecting older adults with severe outcomes and long-term health issues like Post-Acute
Sequelae of SARS-CoV-2 (PASC). Alveolar macrophages (AMs), the primary macrophage population in the
lungs, play crucial roles in lung defense and tissue repair, but can become pro-inflammatory during
infections, leading to tissue damage. Our previous studies identified that TCF4 and β-catenin, key
transcription factors in WNT signaling, have opposing effects on AM responses: TCF4 supports AM stem-
like self-renewal, while β-catenin enhances inflammatory responses. Additionally, AMs from aged mice and
humans exhibit "senescence-like" characteristics, likely contributing to adverse outcomes in the respiratory
tract during aging. The aims of this grant are to elucidate the reciprocal regulation of TCF4 and β-catenin in
dictating AM fate and function, and to investigate the roles of AM senescence, controlled by TCF4, in lung
health and virus-associated acute and chronic diseases during aging. Furthermore, we aim to develop
therapeutic strategies targeting TCF4 to treat age-related acute and chronic conditions following respiratory
viral infections. The successful completion of this application will shed light on the molecular basis
underlying the age-associated defects in host response to viral infection and could open the door for novel
therapeutics for severe acute diseases and/or chronic lung sequelae after viral infection in aged individuals.

Public health relevance
We propose to elucidate the reciprocal regulation of TCF4 and β-catenin in determining lung macrophage fate and function, and to investigate the roles of macrophage senescence, regulated by TCF4, in respiratory health and pathology following viral infection during aging. Furthermore, we aim to develop therapeutic strategies targeting macrophage TCF4 to treat age-related acute and chronic conditions arising from respiratory viral infections. The successful completion of this project will not only illuminate the molecular basis underlying age-associated diseases but also may open the door to novel therapeutics for severe acute diseases and/or chronic lung sequelae following respiratory viral infections during aging.